Environmental Health Sciences Research Center

PROJECT SUMMARY - OVERALL
The Environmental Health Sciences Research Center (EHSRC) will advance and translate research that
addresses environmental health problems across the urban-rural continuum. Rural America faces unique
environmental challenges from exposure to farm chemicals, air and water pollution from livestock and agricultural
production, rural manufacturing, and the green energy economy. The EHSRC is at the forefront of research in
rural environmental health, determining the role of innate immunity and the inflammasome in lung disease; the
role of the microbiome in health and disease; state-of-the-art biomedical imaging with advanced computational
modeling to assess the effect of inhaled toxicants; and applications for distributed sensor networks and data
analytics for exposure monitoring. The Center applies innovations, for example, in advanced -omics
technologies, population-based animal models, and advanced lung imaging, to advance this research. The
EHSRC vision is to be the primary environmental health sciences (EHS) resource for improving the health of
rural residents in the Midwest by stimulating and translating innovative environmental health sciences research.
This is accomplished by enhancing the careers of Center investigators and through our translational research
vision to translate new insights from rural exposures; population health; individual susceptibilities; and pathways
of toxicity, disease, and repair to enhance environmental health literacy, public health practice, regulatory policy,
new clinical treatments, and precision environmental health. Center goals are to: 1) enhance the effectiveness
of environmental health sciences research and extend the focus of research in five Thematic Areas, including
Inflammation and Innate Immunity, Nanoscience, Population Health, Systemic and Redox Toxicology, and Water
Quality; 2) recruit, mentor, and nurture a diverse group of investigators interested in the environmental health
sciences, with an emphasis on recruiting and grooming future leaders in the field; and 3) engage with
communities and other audiences to translate research knowledge toward improving the health and environment
of rural people in the Midwest and the nation. The interdisciplinary research of the EHSRC is organized around
its Thematic Areas and supported by three facilities, the Integrated Health Sciences Facility Core (IHSFC),
Exposure Science Facility (ESF), and Pulmonary Toxicology Facility (PTF). These facilities provide cost-effective
and cutting-edge services and state-of-the-art equipment. An Administrative Core provides transformative
leadership, leverages institutional support, and manages highly effective Pilot Grant and Career Enhancement
Programs that provide resources and mentoring to advance the careers of promising and diverse early-stage
investigators. The Community Engagement Core engages the Center’s audiences to ensure the relevance of
EHSRC research and, in collaboration with the IHSFC, translates research to environmental public health.

Public health relevance
PROJECT NARRATIVE - OVERALL The Environmental Health Sciences Research Center (EHSRC) is the primary environmental health sciences resource for improving the health of rural residents by stimulating and translating innovative environmental health sciences research. This is accomplished by supporting original research addressing rural exposures; population health; susceptibilities; and pathways of toxicity, disease, and repair to enhance environmental health literacy, public health practice, regulatory policy, new clinical treatments, and precision environmental health. The EHSRC supports five Thematic Areas which serve as intellectual hubs, three research facility cores, a Pilot Grant Program, a Career Enhancement Program and a Community Engagement Core that collectively develop fundamental knowledge about living systems to enhance health and reduce the burden of human disease, with an emphasis on rural populations.